The Role of Glycans in Influenza A Virus Mucosal Trapping

PROJECT SUMMARY
The mucosal barrier lining the respiratory epithelium serves as the first line of defense against inhaled
particulates and pathogens such as influenza A virus (IAV). The mucus barrier is composed of large O-linked
glycan decorated gel-forming mucins. These glycans are terminated with different glycans such as sialic acid
(Sia), fucose, and sulfates. Terminal glycans on mucins have an important role in the barrier function of airway
mucus. For example, IAV penetrates the mucus layer through the coordination of its envelope proteins
hemagglutinin (HA), and neuraminidase (NA) which bind and cleave Sia respectively. Fucose and sulfation are
not involved in IAV binding, but contribute hydrophobic and anionic properties of the mucus gel layer,
respectively. Previous research within our lab has demonstrated the importance of mucus pore sizes on IAV
trapping, but the glycan dependence of mucus architecture has yet to be explored. Building upon this, we
propose development of glycotransferase knockout human airway epithelium cultures that lack terminal glycans
(sialic acid, fucose, sulfation) present in the mucus gel to investigate the following aims: In Aim 1, we will
determine how removal of terminal glycans impacts the biophysical properties and transport of mucus as well as
influenza A diffusion and infection. In Aim 2, will determine how removal of these glycans impacts antibody (Ab)
mediated trapping of IAV. To accomplish this, we will employ CRISPR/Cas9 editing targeting the exons of Fut2,
SLC35A1, and PAPSS2, which contribute to mucin fucosylation, sialylation, and sulfation respectively. We will
use fluorescence microscopy based analyses to study the diffusion of IAV and Ab within mucus depleted of
terminal glycans. Additionally, we will use live cell imaging and particle velocimetry to determine how the removal
of these terminal glycans impact mucus clearance efficiency. For the second objective, we will add neutralizing
IAV antibodies to normal and glycan knockout mucus to determine how glycans impact Ab-mediated
neutralization of IAV. Insights into the role of terminal glycans in their maintenance of physical architecture and
viral trapping capabilities of mucus will greatly enhance our understanding of host defense mechanisms critical
to lung health.

Public health relevance
PROJECT NARRATIVE Mucus in the airway is designed to trap inhaled pathogens such as influenza A virus through three primary mechanisms: glycan-pathogen trapping, steric trapping, and antibody-mediated trapping. The interdependence between these mechanisms has yet to be fully explored, as such this project will mechanistically study mucin- associated glycan-mediated trapping and neutralization of influenza virus human airway epithelial models to explore. Successful completion of this proposed study will reveal new insights into IAV pathogenesis and innate defense mechanisms against infection.